IGF::OT::IGF Administrative Costs - Contract Orientation and Kick Off Meeting -Analysis of Anti-Cancer Chemical & Pharm Formulations , HHSN261201700011I, DTP-17-040, 8/01/2017 - 09/30/2017, PRB

Teleconference meeting